Imaging Core

Project Summary: Yale ADRC Imaging Core
The Yale Alzheimer Disease Research Center has the overall goal to advance understanding and treatment of
Alzheimer’s disease (AD). This effort requires integration of a wide array of core functions, including Clinical,
Neuropathology, and Neuroimaging. Human imaging studies allow for the development of imaging biomarkers
of AD, characterization of the temporal sequence of AD pathology, and lead to better assignment of patients to
clinical research studies and clinical trials. Imaging is a major strength at Yale, as exemplified by the breadth
and depth offered by the Yale PET Center and the Yale Magnetic Resonance Research Center (MRRC). In the
PET Center, an example of recent significant work is the introduction of PET synaptic imaging with the SV2A
tracer 11C-UCB-J. In MRI, the Yale MRRC has generated numerous novel methods to characterize an
individual’s functional connectome and relate the functional organization to behavior and clinical variables
Overall, these two Centers develop cutting edge imaging technologies and apply these techniques to answer
important clinical questions. By creating this Yale ADRC Imaging Core (YAIC), we leverage the vast
experience of Yale’s imaging strengths to provide state-of-the-art acquisition and analysis of imaging data and
to focus on the development of novel approaches to AD. The YAIC will provide a common infrastructure for
acquisition, processing, and analysis of multimodal imaging data, to support and train AD investigators and
develop the next generation of imaging tools. The current and future methods will be applied to ongoing
imaging studies to acquire a rich, multi-faceted and multi-modality dataset in human subjects. In addition, the
translational component of this program examines the utility of nonhuman primates (NHPs) as a model for
human AD. The Imaging Core will perform the following specific aims: Aim 1: To develop and optimize PET
image and data analysis strategies to facilitate within- and between-subject comparisons. Multi-tracer within-
subject correlations are important, involving amyloid, tau, synaptic density, and glucose metabolism. Aim 2: To
enhance our MR-based functional connectome modeling to better functionally phenotype patients and link
brain to behavior. This approach provides a functional profile for each individual while localizing the networks
and revealing the network organizing principles supporting these functions. Aim 3: To develop and enrich multi-
modality analyses between PET and fMRI for within- and between-subject studies. The combination of fMRI-
based connectivity with the regional patterns of neurodegeneration measurable with PET provides an ideal
opportunity for understanding the pathways of disease progression. Aim 4: To extend the methodologies
developed for human analysis to NHP data. Ongoing studies in aged NHPs are being performed, providing the
opportunity to compare in vivo PET and MR imaging with post-mortem measures provided by the
Neuropathology Core.

Public health relevance
PROJECT NARRATIVE: Per the program announcement, the Cumulative Project Narrative has been included in the Overall Component, Other Project Information section.